Tracking brain structural trajectories for early detection and prognosis of Alzheimer's Disease

Project Summary
Tengfei Li, Ph.D, is a statistician committed to developing advanced statistical methods to better understand the human
brain function and structure, the aging process, cognition and brain disorders using multi-modal neuroimaging and genetic
data. The research he proposes, entitled “Tracking brain structural trajectories for early detection and prognosis of
Alzheimer's Disease”, will unify multi-center multi-modal datasets using cutting-edge statistical and machine learning
techniques. The result will be a comprehensive set of life-span brain structural reference standards and a centile-based
explainable artificial intelligence (AI) system, which facilitate timely and precise detection of brain structural changes in
the early stages of Alzheimer's Disease (AD) and AD related dementias (ADRD) and aid in the diagnosis and prognosis of
the early stages of AD.
Candidate: Dr. Li is a Research Assistant Professor in the department of Radiology, University of North Carolina at
Chapel Hill. He completed his Ph. D in probability and mathematical statistics prior to his postdoctoral fellowship in
biostatistics at the University of Texas MD Anderson Cancer Center. Dr. Li's previous work, which has been published in
high-impact journals such as Science and Nature Genetics, focuses on imaging-genetic analysis and big data integration.
The proposed career development plan will build upon his previous training with four training goals to enhance his
trajectory toward becoming an independent investigator: 1) Build a solid understanding of the neurodevelopmental basis
of AD/ADRD; 2) Develop novel methodologies and strengthen in-depth understanding of AI in neuroimaging and AD/
ADRD analyses; 3) Develop professional skills to analyze multicenter big data; and 4) Establish leadership, expand
collaborative networks, and translate diagnostic tools into clinical practice. Dr. Li and his primary mentor, Hongtu Zhu,
Ph.D, have assembled a strong team of co-mentors to guide Dr. Li through the proposed training and research activities.
Research: Despite an increased availability of neuroimaging datasets, the analysis of brain structure change by AD is
limited by narrow age ranges, small sample sizes, and a lack of critical covariates. Besides, there is no reference standard
against which to anchor individual differences in brain morphology from multisite images that may or may not align with
growth charts. Dr. Li proposes to overcome these limitations by establishing life-span brain structural developmental
reference standards that can be used to identify abnormal brain aging/developmental patterns in the early AD phases,
including cortical/subcortical structures and white matter tracts. In Aim 1, he will develop a Functional Harmonization
Regression Modeling (FHRM) framework to integrate multi-site data; in Aim 2, he will build a brain Local Growth
Curve Modeling (LGCM) system to build the normal brain structural aging trajectories and track their variations
associated with early phases or high-risk AD groups; and in Aim 3, he will develop a computationally efficient, easily
interpretable and state-of-the-art Centile-based Explainable AI (CEAI) system in delineating the preclinical AD, MCI
and AD transitions. This award will provide Dr. Li with the training and research needed to be successful for future, high-
impact multi-center multimodal studies and behavioral/cognitive performance related to brain aging and AD. This will
significantly contribute to the field and support Dr. Li's transition towards scientific independence.

Public health relevance
Project Narrative Brain structural changes caused by Alzheimer's Disease (AD) are typically believed to be late in life, since the hallmark pathological changes including beta-amyloid plaques and tau tangles are thought to develop over many years. However, recent research suggests that these changes might start earlier than we once thought, which motivates us to explore the possibility of spotting the AD's early signs in the structural change of the brain. Our research aims to create a comprehensive map detailing how the brain naturally changes throughout life, which facilitates distinguishing normal aging from the early stages of AD and identifying the transitions when patterns in brain aging signal a higher AD risk.